Supplement: Design and Model-Based Safety Verification of a Volitional Sit-Stand Controller for a Powered Knee-Ankle Prosthesis

Childcare supplement request for 1-F31-EB-032745-01. The information below is for the
original submission.
ABSTRACT
Sit-stand transitions, the motions executed by individuals to stand up or sit down, are an important
determinant of overall mobility and a common source of falls. Unilateral amputees using standard
passive prostheses are further challenged by sit-stand transitions due to muscle and joint
asymmetries they exhibit between the sound and amputated sides, often resulting in debilitating
back pain. Powered knee-ankle prostheses can produce enough torque to assist meaningfully
during sit-stand transitions and can meet design criteria such as producing smooth motion on the
amputated side that matches the sound side. Controllers for these prostheses can be designed
to allow user-driven control of the leg. However, the production of high torques not directly
commanded by the user comes with increased risks. This is of particular concern because these
legs must be adopted outside of controlled lab environments. Thus, any powered prosthesis must
demonstrably meet design and safety criteria. While safety-critical medical devices, such as
pacemakers, are subjected to extensive testing and validation procedures, there is no agreed-
upon standard in the powered prosthetics field for how to define and measure safety. Prior work
on sit-stand controllers has focused only on measuring a limited number of outcomes with respect
to one design criterion on a small number of subjects, providing no guarantees about safety. The
set of techniques known as formal verification provides powerful tools to reason about the
behavior of systems that are composed of interacting mechanical, software, and biological
modules. Given a model of a system, formal verification allows us to probe the system’s behavior
over an infinite range of possibilities that cannot be replicated in the lab during a typical testing
session. These methods can then guide real-world testing, and alert system designers to
problematic regions of execution. In this project, I propose to apply formal verification techniques
to design a volitional controller for sit-stand transitions with provable safety guarantees, using
physics-based models and novel mathematical formulations of safety.
The University of Michigan Robotics Institute is one of the top institutes of its kind in the US and
provides an ideal environment and infrastructure for the successful completion of this research.
The Robotics Institute gait lab has all of the necessary equipment needed for powered prosthesis
research, including two state-of-the-art prosthetic legs, and access to advanced computational
resources such as the Great Lakes high performance computing cluster. Drs. Umberger and Ozay
have proven expertise relevant to the aims of this project, and will provide mentorship that will
guide my research, my training, and the attainment of my career goals.

Public health relevance
Childcare supplement request for 1-F31-EB-032745-01. The information below is for the original submission. PROJECT NARRATIVE The proposed research is relevant to public health because the clinical application of powered prosthetic legs can significantly improve community mobility and therefore quality of life for nearly a million American amputees. As sit-to-stand motion is a particularly important indicator of mobility, this project will generate a method to safely control sit-to-stand motion for above-knee amputees using a powered knee-ankle prosthesis while developing novel techniques to quantify safety. This aligns with the missions of the Mathematical Modeling, Simulation and Analysis program area of the NIBIB and the Devices and Technology Development program area of the NICHD National Center for Medical Rehabilitation Research.